Clinical and Translational Science Award

PROJECT SUMMARY
While there is widespread recognition that AI applications in digital health raise ethical questions, there is a
lack of research on the ethical principles used by developers and the specific needs for ethical assessment of
AI. Specifically, there is a lack of consensus on whether and how AI approaches in digital health include goals
of justice, equity, diversity and inclusion (JEDI). We will conduct an in-depth analysis of the ethical principles
identified in the scientific literature on the development of AI approaches in clinical applications and how JEDI
is conceived and integrated into research and development. To achieve our study objectives, we will fulfill the
following aim: Investigate JEDI in ethical frameworks applied to research on AI in digital health and create
educational case studies for identifying ethical issues related to JEDI and discussing potential approaches to
integrate JEDI goals.

Public health relevance
PROJECT NARRATIVE This study will investigate how justice, equity, diversity and inclusion (JEDI) is addressed by researchers who integrate of personal health data into artificial intelligence tools and approaches. We will conduct an in-depth analysis of the ethical principles identified in the scientific literature and how JEDI concerns are taken into account. Our findings will contribute to the development of educational case studies that describe the implications of JEDI in AI development.